Targeting STAT3 with Novel Thiomorpholino Antisense Oligonucleotides for Cancer Therapy

Project Summary
Vesicle Therapeutics, Inc. (VTI) is developing a targeted antisense oligonucleotide (ASO) using
innovative thiomorpholino chemistry (TMO) to treat head and neck cancer, particularly squamous
cell carcinoma (HNSCC). Head and neck cancer ranks as the sixth most common cancer type,
with up to 90% of these tumors being squamous cell carcinoma (HNSCC). The survival rate
remains low due to the relatively low responsiveness to treatments and severe drug resistance.
Various therapeutic approaches have been attempted to inhibit STAT3, but no STAT3-specific
therapeutics have been approved yet. VTI’s ASO is designed to selectively inhibit the oncogenic
STAT3α isoform while preserving the tumor-suppressive STAT3β, aiming to treat the tumor and
its microenvironment (TME) more effectively and with less toxicity than current approaches. Our
preliminary results show that the STAT3 TMO is effectively taken up by both tumor and immune
cells, accumulates in the nucleus, alters the STAT3α/STAT3β ratio favorably, and suppresses
myeloid cell expansion induced by tumor cells, all with low systemic toxicity. The Phase I project
focuses on synthesizing sufficient quantities of STAT3 TMO, evaluating its effects on gene
expression, determining its pharmacokinetics, and assessing its safety and efficacy in preclinical
models. Positive outcomes from proposed studies will set the stage for developing a novel isoform
selective STAT3 targeted therapy for treating head and neck cancer and improving patient
outcomes.

Public health relevance
Project Narrative The goal of this project is to develop and commercialize a novel antisense oligonucleotide (ASO) therapy that selectively targets the oncogenic form of STAT3 for the treatment of head and neck cancer.